Investigation of nociceptive endogenous opioid dynamics in the periaqueductal gray

PROJECT SUMMARY/ABSTRACT
Chronic pain is a highly prevalent and debilitating clinical problem that negatively impacts the health and
quality of life of millions of people. A common and relatively effective strategy to provide acute relief to chronic
pain patients is through prescription of opioid compounds. However, opioid analgesics carry substantial abuse
and overdose liabilities, contributing heavily to the ongoing opioid epidemic. These negative consequences of
exogenous opioids result from their diffuse action at endogenous mu opioid receptor-expressing (MOR) brain
regions beyond the pain-encoding neurocircuitry that they are intended to modulate. To meet the pressing
demand for effective and safe analgesics, new, targeted pain therapies must be developed that emerge from
focused research on the endogenous opioidergic cell types and neural circuits involved in pain perception (i.e.,
nociception) and opioid-induced analgesia. The ventrolateral periaqueductal gray (vlPAG) is critical in this regard
as it can produce robust antinociception through MOR and the enkephalin peptides expressed by the cells and
afferents it contains. Yet, long-standing questions remain concerning the endogenous opioid signaling dynamics
in the vlPAG that are recruited by acute and chronic pain conditions. This proposal will begin to fill these gaps in
knowledge with a combination of novel tools: genetic recombination in defined neural populations, MOR specific
promoter viruses, and a fluorescent enkephalin sensor. Combined, these approaches allow for unprecedented
in vivo access to the pre- and postsynaptic components of endogenous opioid transmission in the vlPAG. Thus,
I will test my central hypothesis that the vlPAG contains a functional nociceptive MOR-expressing ensemble
that is modulated by enkephalin release from forebrain and local interneurons to produce antinociception. In Aim
1, I will use classical pain assays to identify the molecular identity and calcium signaling activity patterns of the
nociceptive MOR-expressing neural ensemble in the vlPAG (vlPAGNoci/MOR). I will further determine the functional
role of vlPAGNoci/MOR neurons in antinociception through optogenetic inhibition during acute and inflammatory
pain states. In Aim 2, I will identify and manipulate two putative enkephalinergic inputs to the vlPAG, local vlPAG
interneurons and long-range medial nucleus of the central amygdala (CeM) projections, to determine their
respective contributions to nociception. How these enkephalingeric afferents interact with the MOR-expressing
neurons in the vlPAG will also be determined. The results of these proposed experiments will advance our
understanding of endogenous opioid signaling processes that are engaged and altered by acute and chronic
pain conditions. By elucidating the components of the endogenous opioid circuitry of the vlPAG that produce
analgesia, relief from chronic pain may be realized by future therapies that target this system while lacking the
harmful addictive properties of current opioid drugs. Completion of this Fellowship proposal will achieve my
training goals to expand my experimental expertise and establish myself as an expert in pain and opioidergic
neurocircuitry.

Public health relevance
PROJECT NARRATIVE Chronic pain is a highly debilitating disorder that adversely impacts the lives of millions of people. Opioid analgesics are commonly prescribed for chronic pain relief because they modulate endogenous opioid signaling in pain-encoding neural circuits; however, these drugs carry substantial abuse and overdose liabilities due to their broad actions on reward- and breathing-related brain regions. For this reason, my proposal will interrogate the critical pain-responsive endogenous opioid circuit of the periaqueductal gray to enhance our understanding of the cell types and neural pathways engaged by opioid compounds and inform future neurocircuit-focused chronic pain therapies that lack the harmful risks of opioid drugs.